Investigating structure activity relationships in autoprocessing by HIV-1 protease

Project Summary
The long-term goal of this project is a detailed mechanistic understanding of the autoprocessing
mechanism by which viral proteases cut themselves out of precursor polyproteins. Autoprocessing is
critical to the life cycle of many viruses, but is poorly understood in part because the structure of
protease in polyproteins is highly dynamic. In Aim 1, we will determine the potency of a panel of
inhibitors for autoprocessing of HIV-1 protease. The results from this aim will provide a guide to
understand the physical properties at different positions on inhibitors that govern binding. In Aim 2, we
will use deep mutational scanning to determine how all possible point mutations in protease impact
autoprocessing efficiency. The results from this aim will determine the physical requirements at each
position in protease for autoprocessing. Together, these aims will provide a detailed understanding of
the physical underpinnings of autoprocessing by HIV-1 protease.

Public health relevance
Project Narrative Many viruses that infect humans rely on a protease that must cut itself out of a precursor polyprotein. Investigating the mechanism of this process will help us to understand viral life cycles with the potential for new avenues of antiviral therapy.